Hepatoprotective Mechanisms of Systemic Bile Acid Transporter Inhibitors

The overarching goal of this application is to advance our understanding of the role of the Apical sodium-
dependent bile acid (BA) transporter (ASBT; also called IBAT) in the pathogenesis of cholestatic liver disease
and associated kidney injury, and to elucidate the therapeutic mechanisms of action of systemically acting
ASBT inhibitors. In addition to ileal enterocytes, ASBT is expressed by kidney proximal tubule epithelial cells
to limit BA loss in urine. ASBT is also expressed by cholangiocytes in the liver, where ASBT can mediate
cholehepatic shunting of BAs. In contrast to ileum, much less is known regarding the ASBT’s role in those
tissue compartments in cholestatic liver disease or whether ASBT inhibition in kidney and biliary tract may
have therapeutic benefit or deleterious effects. BAs have been implicated in a disorder called Cholemic
Nephropathy (also called Bile Cast Nephropathy) and may be an underestimated contributor to kidney injury
in patients with liver disease. Guided by the applicant’s previously published work and strong preliminary data,
two specific aims are proposed to address those gaps. Specific Aim 1 is designed to elucidate the kidney
ASBT’s contribution to the hepatoprotective actions of systemic ASBT inhibition and define the role of kidney
ASBT in the pathogenesis of cholestatic liver disease-associated kidney injury. This will be accomplished
using a novel kidney-specific ASBT knockout, state-of-the-art imaging approaches, and surgical and genetic
models of cholestasis, including models with a “humanized” BA pool (Cyp2c70 knockout mice). The time
course and extent of liver and kidney injury will be determined to elucidate the relationship of kidney ASBT
and urinary BA elimination to development of the hepatic and associated kidney injury. Human renal tubule
organoids will be used to interrogate molecular mechanisms by which BAs alone or in combination with other
liver-derived cholephiles induce renal proximal tubule cell toxicity. Specific Aim 2 is designed to define the
role of the biliary tract ASBT in the pathogenesis of cholestatic liver disease and the hepatoprotective actions
of systemic ASBT inhibition. This will be accomplished using a novel liver-specific ASBT knockout mouse,
state-of-the-art imaging approaches, and surgical and genetic models of cholestasis, including models with a
“humanized” BA pool (Cyp2c70 knockout mice). The time course and extent of liver injury will be determined
to elucidate the relationship of cholangiocyte ASBT and cholehepatic BA shunting to development of
hepatobiliary disease. These innovative studies will yield novel and potentially paradigm-changing insights to
the contribution of kidney and biliary tract BA reabsorption to the pathogenesis of cholestatic liver disease
and the associated kidney injury (Cholemic Nephropathy). The findings are predicted to be impactful and will
guide development of new, safe, and effective approaches to treat the multi-organ damaged associated with
cholestasis.

Public health relevance
The proposed research is relevant to public health because it addresses a critical unmet medical need for patients with liver disease and associated kidney injury. The studies in this proposal will provide key and potentially paradigm-changing insights to the role of kidney and biliary tract bile acid transport in the development of those disorders. The studies are predicted to have a therapeutically significant impact on the development of medical therapies for patients suffering from cholestatic liver diseases such as Primary Biliary Cholangitis, Progressive Familial Intrahepatic Cholestasis, and Alagille Syndrome.